Initiation of DNA Replication at Cell Origins in Yeast

DESCRIPTION (provided by applicant): The goal of this research is to determine the mechanism and regulation of the initiation of DNA replication in eukaryotic cells. It is clear that for maintenance of the integrity of the genome frm one cell generation to the next, DNA and its associated chromatin structures must be duplicated in a highly controlled and accurate manner. Interruption of these controls may promote genome instability and lead to neoplastic transformation in somatic cells or result in mutations in the germ line that can cause many different disorders. Moreover, the DNA replication proteins represent tangible targets for therapeutic intervention and diagnosis of proliferation of cancer cells, and other proliferative disorders. The initiator protein (ORC) cooperates with a series of DNA replication proteins, including Cdc6, Cdt1 and the MCM2-7 hexamer to establish at origins of DNA replication a pre-Replicative Complex (pre-RC) that facilitates later initiation of DNA synthesis at each origin. Recent progress has enabled the assembly of the pre-RC in vitro with purified proteins. The proposed research in this application will investigate, using the yeast S. cerevisiae, how the initiation of DNA replication occurs following pre-RC assembly and how this process is regulated by the Cdc7-Dbf4 (DDK) protein kinase and by an intrinsic inhibitor of initiation of DNA replication within the Mcm4 subunit of the MCM2-7 complex. The proposed research will also investigate how the core histones within nucleosomes, the fundamental structural unit of chromatin in eukaryotic cells, are disrupted during DNA replication and transferred to the leading and lagging strands of the newly synthesized DNA. PUBLIC HEALTH RELEVANCE: DNA replication is the process whereby the genome is duplicated prior to segregation of the resulting sister chromatids during mitosis or meiosis. During mitotic exit or during G1 phase, a pre-Replicative Complex is assembled each origin of DNA replication that renders each origin competent for subsequent initiation of DNA replication. This project will examine how the initiation of DNA synthesis occurs and how it is regulated, as well as investigate how chromatin is inherited.

Public health relevance
DNA replication is the process whereby the genome is duplicated prior to segregation of the resulting sister chromatids during mitosis or meiosis. During mitotic exit or during G1 phase, a pre-Replicative Complex is assembled each origin of DNA replication that renders each origin competent for subsequent initiation of DNA replication. This project will examine how the initiation of DNA synthesis occurs and how it is regulated, as well as investigate how chromatin is inherited.